Remediation of Perfluorinated Chemicals in Water Using Novel High-Affinity Polymer Adsorbents

Abstract
Contamination of water supplies by toxic per- and polyfluoroalkyl substances is a major health and environmental
issue impacting society today. Given the environmental persistence of these contaminants and their established
linkage to serious health risks, it is imperative that safe, efficient, and cost-effective PFAS remediation
technologies be developed that can eliminate these contaminants from the U.S. water supplies. With the
tightening of health-based contamination limits and the expansion of regulated PFAS structures, the impacts of
PFAS contamination are now estimated to affect over 200 million Americans. NIEHS sponsored DEXSORB
adsorbent represents a breakthrough solution for the safe, rapid, and cost-effective removal of short- and long-
chain PFAS compounds, including PFOA and PFOS from water. It takes exacting technology to remove PFAS
compounds at the trace levels being mandated by States and the EPA. Made from renewable cyclodextrins,
DEXSORB’s ability to selectively target PFAS compounds at trace concentrations with rapid uptake, high
capacity, and resistance to fouling make it ideally suited for use in private and municipal water treatment systems.
Working with environmental partners, Cyclopure has demonstrated the superior performance and favorable life
cycle economies of DEXSORB in pilot water treatment activities. To advance further, specific milestones that
upon completion will help Cyclopure transition to full commercialization stage have been identified in this CRP
proposal. Cyclopure’s main objective in this program will be to seek support for regulatory and manufacturing
assistance. Both areas are critical prior to the commencement of full-scale manufacturing and commercialization
activities. Safety and health related information and associated experimental data will be collected and organized
for material registrations and certifications as required by regulatory agencies including EPA and NSF
International. Activities under manufacturing assistance will support developing an optimal purification method
that is expected to provide significant cost and process improvements in a full-scale manufacturing environment.
Successful completion of this proposed work will enable Cyclopure to transition to large-scale production and
work with industry partners to make DEXSORB available to provide PFAS removal for consumer and municipal
applications.

Public health relevance
Project Narrative The increasing number of locations contaminated with per- and polyfluoroalkyl substances (PFASs) at high levels in drinking water resources represents a significant public health issue. The existing treatment technologies cannot treat and eliminate PFASs in an effective and sustainable manner. Cyclopure’s adsorbent technology based on renewable resources is fully capable of removing, recovering, and destroying PFASs in various types of water resources and can be engineered for direct consumer use and large-scale water treatment systems serving public.